STUDY OF INTRAVENOUS ILMOFOSINE ADMINISTERED ONCE A DAY FOR 5 DAYS EVERY 28 DAYS

This is a phase I study of ilmofosine, a new synthetic alkyl lysophospholipid, which may possess cytostatic properties and be useful as an antineoplastic agent.